Acquisition of timsTOF Pro for Complex Lipidomic Analyses

ABSTRACT
The Mass Spectrometry Research and Education Center (MSREC) at the University of Florida is
submitting a new proposal requesting funds for the purchase of a Bruker timsTOF Pro Trapped Ion
Mobility Spectrometry Quadrupole Time-of-Flight Mass Spectrometry system to be installed and
operated in the MSREC at the University of Florida. We are requesting this instrument specifically for
the “4D-Lipidomicsä” analysis of complex lipids for a variety of research programs. This Bruker
timsTOF Pro LC-MS will add ultra-high-resolution trapped ion mobility (TIMS) with PASEF MS/MS
capabilities to UF NIH-funded investigators that currently is unavailable in the Southeast region and the
North/central region of Florida. MSREC serves more than 150 research groups on the UF campus
from more than 25 departments, centers, and colleges. More than 30 non-UF academic institutions and
industrial companies also frequently utilize the MSREC core lab.
The complete system will include the timsTOF Pro LC-IM-MS/MS system with measurements in both
MS and Parallel Accumulation Serial Fragmentation (PASEF), an UltiMate 3000 RSLCnano LC system,
Apollo II ion funnel ESI source, SimLipid Enterprise Edition Academic, upgrade to Compass
Metaboscape 2021 from currently licensed version 5.0, Library MS-MetaboBase 3.0 and Wiley Metlin
Mass Spectral Database.
The fields of metabolomics, proteomics, and lipidomics are now recognized as playing a critical role in
systems biology and are becoming the focus of the development of diagnostic tests, novel drug
therapies, personalized medicine, and understanding of infectious diseases, cancer, and metabolic
disorders. The proposed timsTOF Pro system will be used for measuring complex mixtures of lipids
requiring ultra-high-resolution ion mobility mass spectrometry for detection, identification, and
quantitation of those complex mixtures. This data will in turn improve the outcomes of the health related
goals of the projects assembled in this proposal, examples including: development of novel
therapeutics for cancer and other diseases; fundamental biology of the interactions between genetic
factors and environmental factors in the process of animal aging; studying multidrug-resistant Gram-
negative bacteria “superbugs” and antibiotics; the relationship between SPMs to abdominal aortic
aneurysms; understanding the structural mechanisms by which membrane lipids regulate GPCR function; and
developing and understanding the mechanism of anthelmintics.
While the requested instruments capabilities are targeted to the needs of the users and health-related
goals of the research projects listed herein, the instrument will also provide substantial improvements
in data quality and throughput for the community of system biology researchers at the UF.

Public health relevance
PROJECT NARRATIVE The fields of metabolomics, proteomics, and lipidomics are now recognized as playing a critical role in systems biology and are becoming the focus of the development of diagnostic tests, novel drug therapies, personalized medicine, and understanding of infectious diseases, cancer, and metabolic disorders. The proposed Bruker timsTOF Pro system will be used for the 4D lipidomic workflow and will analyze complex mixtures of lipids requiring high-resolution trapped ion mobility tandem with PASEF MS/MS for detection, identification, and quantitation of those complex mixtures. This data will in turn improve the outcomes of the health related goals of the projects assembled in this proposal.